NARMS: Antibiotic Resistance Surveillance in Retail Food Samples from South Dakota and North Dakota

PROJECT SUMMARY/ABSTRACT
The objective of the FDA-NARMS cooperative agreement program (CAP) is to build a
network of 30 laboratories distributed throughout the United States to determine the
prevalence of antimicrobial resistance among bacteria (Salmonella, Campylobacter,
Aeromonas, Vibrio, E. coli, CPE, and enterococci) isolated from samples of chicken,
ground turkey, ground beef, ground pork, tilapia, salmon and shrimp purchased from
grocery stores. Our proposed portion of this CAP grant would be to collect retail meat and
seafood samples from South Dakota and North Dakota grocery stores.
Retail meat and seafood samples will be brought back to the Food Safety Microbiology
(FSM) Laboratory in the Animal Disease Research and Diagnostic Laboratory (ADRDL) at
South Dakota State University (SDSU). All samples will be tested for the presence of
Salmonella, Campylobacter, Aeromonas, Vibrio, E. coli, CPE and Enterococci using
established food safety analysis protocols. The microbes isolated from these food
samples will be shipped to FDA-CVM for analysis of antibiotic resistance profiles. Isolates
of Campylobacter, Salmonella, and E. coli from retail meats and Vibrio and Aeromonas
from seafood will be sequenced onsite and uploaded to the FDA database utilizing existing
GenomeTrakr methodologies. These results will be compiled by the FDA and distributed
back to the FSM lab for dissemination to the Cooperative Extension Services, Consumers,
and Producers.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health, providing an assessment of the current state of antimicrobial resistance among bacteria that are commonly found in meat and seafood consumed by humans. The results of this study will be essential, allowing the FDA to determine parameters for antimicrobial use in the treatment of animals, and for developing “One-Health” interventions to reduce the spread of antimicrobial resistance between animals and humans.